MUSC SCORE Career Enhancement Core

ABSTRACT
The MUSC SCORE Career Enhancement Core (CEC) enhances and expands foundational research training for
Early Stage Investigators dedicated to clinical and translational research on stress-related sex and gender
differences via a mix of formal didactic modules, “hands-on” experiential learning opportunities, and inter-
program research offerings leveraging the rich portfolio of training programs and research expertise across the
MUSC campus. The SCORE CEC focuses on facilitating the development of skills in multiple domains, including:
(1) knowledge and skills to conduct research focused on sex and gender differences; (2) scientific knowledge
and professional development; (3) fundamental research skills; (4) dissemination and presentation of research
findings; and (5) scientific writing. The substantial expertise in stress-related research at MUSC ensures our
ability to mentor individuals in early stages of their research careers to contribute significantly to the
understanding and treatment of stress-related diseases and disorders. Further, the SCORE CEC works
synergistically with other training programs on the MUSC campus to attract and promote faculty development in
research focused on sex and gender differences.

Public health relevance
PROJECT NARRATIVE The SCORE Career Enhancement Core (CEC) provides a formal, intensive program of mentored clinical and translational research training and career development activities to promote junior scholars in the area of sex- and gender-based clinical and translational research focused on the impact of stress on human health. Training scientists with an understanding of the role of sex and gender in the etiology and pathophysiology of specific disease states will allow for optimization of personalized approaches to diagnosis and treatment essential to improving the health of both men and women.